Lrp5 and Lrp6 signaling in bone mechanotransduction and metabolism

The search for molecular targets and pathways that can be manipulated to improve bone properties is a highly
active area of investigation. Recently, particular interest has been expressed in targeting biomolecules that can
augment mechanical signaling in bone; the next generation of osteoporosis drugs is likely to work in
conjunction with physical activity/loading in order to disproportionately direct new bone formation to the skeletal
loci that need it most (i.e., those loci that endure the greatest strains and are at the greatest risk of failure). The
WNT signaling pathway has emerged as a key regulator of bone mass and strength, but also of bone cell
mechanotransduction. Recent clinical approval of the osteoporosis therapy EvenityTM (i.e., Romosozumab-
aqqg) has highlighted the utility and potency of targeting the WNT pathway to improve skeletal properties and
fracture resistance. However, the FDA issued a black-box label to the product because of its side effects on
cardiovascular function and health. Recent work suggests that the effects of WNT stimulation on bone
formation can be isolated from those on cardiovascular function, but the molecular mechanisms driving these
disparate processes are completely unknown. The goal of the present is application is to understand precisely
how LRP5 and LRP6—two structurally related cell surface proteins that function as WNT co-receptors—differ
in their skeletal and non-skeletal contexts, with the goal of exploiting signaling differences to improve clinically
based WNT therapeutic outcomes (e.g., sclerostin inhibition). Among the key questions addressed are: (1) Do
LRP5 and LRP6 exhibit different predilection, or selectivity, to different WNT ligands in bone cells in vivo? (2)
Does LRP5 activation trigger different downstream signaling networks than activated LRP6? (3) Among the
known canonical WNTs, which activate only LRP5, only LRP6 or both? (4) Is LRP6 involved in
mechanotransduction in bone (overuse and/or disuse)? (5) Can activation of LRP5 alone (through sclerostin
antibody-mediated inhibition or by gain-of-function mutation in the receptor) improve bone properties to a
greater extent than activation of LRP6 alone? And (6) are cardiovascular effects differentially affected by
LRP5 vs LRP6 signaling (in isolation)? We will use cutting-edge mouse models, microscopic techniques, single
cell and spatial transcriptomic approaches, mechanotransduction models, and radiographic/histologic/
biochemical approaches to reveal the underlying biology and therapeutic potential/differences of LRP5 and
LRP6 in bone tissue. The project is a continuation of the close collaboration between the Robling (Indiana
Univ.) and Warman (Harvard Univ.) labs, an extremely fruitful partnership for more than 17 yrs. We have
assembled a unique combination of expertise, resources, biological models and tools, and technical innovation
to elucidate and distinguish the roles of LRP5 and LRP6 in bone biology.

Public health relevance
Project Narrative The research program described in this application seeks to elucidate the molecular biology of two related cell surface receptors known as LRP5 and LRP6. Human patients with mutations in the genes for these proteins exhibit skeletal phenotypes (very dense bone) that attest to the therapeutic potential of harnessing their activity to improve skeletal health in patients with low bone mass disease. We will study mice that express different forms of LRP5 and LRP6, to determine the mechanisms of action for these receptors, and whether they work as a function of exercise to improve bone properties.